Administration

The Administrative Core will be at the University of Minnesota and be under the direction of Dr. Timothy Schacker. The core will have several responsibilities: 1) to facilitate communication between investigators, 2) manage all regulatory matter with the clinical protocols at the University of Minnesota IRB and General Clinical Research Center (GCRC), 3) oversee budget management for all protocols and cores, 4) coordinate quarterly meetings (via teleconference) for investigators to review data and also plan two annual meetings between investigators and the external advisory board (EAB), assist investigators with preparation of manuscripts and required annual reports, 6) oversee administration of the project-wide data base to ensure that it is meeting the needs of all investigators, 7) track and manage distribution of tissues and samples between investigators, and 8) coordinate activities of the Safety Monitoring Committee (SMC). Assisting Dr. Schacker in completing functions assigned to this core will be an Administrative Assistant. This person will organize and maintain core functions as appropriate. This includes scheduling, writing, and maintaining regulatory applications and amendments, tracking specimens, coordination of the changing needs of the web-based database between investigators and the University of Minnesota Academic Health Center Information Technology Department (AHCIT) which hosts the database.